Multi-level associations between medical marijuana laws and substance use disorder treatment

TITLE: Multi-level associations between medical marijuana laws and substance use disorder treatment
Medical marijuana laws (MMLs) have been increasingly adopted throughout the United States; more than
half of people live in states that permit medical use of marijuana. While MMLs have been associated with
treatment admissions for substance use disorders (SUDs), the relationship between MML and SUD treatment
is complex and dynamic and can vary based on specific MML provisions. Marijuana dispensaries, for example,
have been associated with increases in marijuana treatment and decreases in opioid treatment admissions.
However, there are critical gaps in the literature regarding the mechanisms through which MMLs can affect
SUD treatment use and related outcomes. The proposed research takes a multidisciplinary approach to
understand and isolate the effects of MML on SUD treatment across gender and racial/ethnic groups,
accounting for individual- (e.g., perceptions), community- (e.g., criminal justice), and state-level (e.g., Medicaid
expansion) factors. Estimating the effect of structural factors such as MMLs on SUD treatment use could have
significant public health impact, as SUDs are associated with a variety of negative health consequences, and
the majority of people who meet SUD criteria do not receive SUD treatment. MML effects on individual SUD
treatment need and perceptions will be estimated using data from the restricted use National Survey on Drug
Use and Health from 2004 onwards. MML effects on criminal justice referrals to SUD treatment will be
estimated using the 1992-2014 Treatment Episodes Data Set. The effects of MMLs on health outcomes and
service costs between 2004 and 2014 will be assessed in a cohort of adults with Medicare/Medicaid.
Interactions between gender and race/ethnicity will be tested in order to determine whether MMLs are
contributing to changes in health care disparities. The research in this K01 proposal supports the National
Institute on Drug Abuse objective to “assess the impact of federal, state-, and systems-level policies related to
drug use and substance use disorders on public health and well-being.” Three specific training areas will be
incorporated to carry out the research aims, including: (a) structural contributors to health care disparities in
SUD treatment; (b) dynamics between criminal justice, health policy, and treatment systems; and (c) health
financing and health economics analysis. The ambitious training and research aims are feasible in the 5-year
K01 award with the support of the interdisciplinary mentorship team at Columbia University (Drs. Martins,
Metsch, Hasin, and Muennig) and collaborators (Dr. Fagan, Crystal and Alexandre), culminating in the
development of an R01. The career development plan will support the applicant’s goals and trajectory towards
research independence.

Public health relevance
PROJECT NARRATIVE Understanding the effect of medical marijuana laws and other health policies on substance use disorder treatment uptake is a public health priority, as the majority of people who meet disorder criteria do not receive services. The goal of this K01 is to estimate associations between medical marijuana laws and substance use disorder treatment using multiple existing data sources. Findings will inform how changing marijuana policy can affect health care use by gender and race/ethnicity in the United States.